Epigenetic regulation of vascular endothelial genes and laminar flow atheroprotection

The primary goal of this supplement project is to investigate whether manipulating the epigenetic modifier EZH2
expression and activity could alleviate cerebrovascular inflammation and the protect against Alzheimer disease
(AD). Increasing evidence supports that cerebral vessel pathology is an important risk factor for AD.
Cerebrovascular disease is an important cause of cognitive impairment and dementia in elderly patients.
Moreover, neuroinflammation is a central mechanism in AD. New findings also reveal that late-onset AD in
human is driven by epigenetic changes in the brain, suggesting that epigenetic marks could be the target of
future Alzheimer's therapies. Thus, this Alzheimer’s-focused administrative supplement is a logical expansion
and within the scope of our active parent R01 grant entitled “Epigenetic regulation of vascular endothelial genes
and laminar flow atheroprotection”. EZH2 (Enhancer of Zeste Homolog 2) is a histone methyltransferase and a
catalytic component of polycomb repressive complex 2 (PRC2), catalyzes tri-methylation of histone H3 at Lys
27 (H3K27me3) to regulate gene expression through epigenetic machinery. During conducting the studies
proposed in our parent grant, my laboratory has discovered that the atheroprotective laminar blood flow
decreased expression of EZH2 and the epigenetic marker H3K27me3 in vascular endothelial cells, and we have
recently published an article showing that endothelial EZH2 inhibition attenuated vascular inflammation. During
working on our parent RO1 project to investigate a critical role of EZH2 in regulation endothelial inflammation
and atherosclerosis, we have also generated tamoxifen-inducible endothelium-specific EZH2 knockout mice and
littermate control floxed wild-type mice. With these genetic mutant mouse models in hands, we are in an ideal
position to assess whether modulating epigenetic marks would correct vascular inflammation in brain vascular
beds and AD pathologies. In this proposal, we will investigate the new role of the epigenetic modifier EZH2 in
regulation of brain inflammation and beta-amyloid deposit in 5XFAD transgenic mice (from Jackson laboratory)
by crossing our conditional inducible endothelial-specific EZH2 floxed mice. 5XFAD moue model recapitulates
major features of AD amyloid pathology and is a useful model of neurodegeneration and amyloid plaque
formation. Furthermore, we will exploit the potent EZH2 inhibitor GSK126 to test whether pharmacological EZH2
inhibition ameliorates neurovascular inflammation and amyloid beta pathologies in 5XFAD mice. Collectively, the
studies proposed herein provide a framework to begin defining a potential role of EZH2 in antagonizing
cerebrovascular inflammation and the amyloid plaque formation in AD. The findings resulting from these studies
should help us find a new strategy to prevent and treat Alzheimer's and other types of dementia, and eventually
translate our research advances into improved care for people with AD.

Public health relevance
Alzheimer’s disease is the most common neurodegenerative disease and the most prevalent cause of dementia that can lead to the impairment of memory, thinking and behavior. Currently there is no cure for Alzheimer’s disease, signifying that new and effective treatment strategies should be explored. The proposed studies, focusing on investigating the potential role of the epigenetic modifier EZH2 in Alzheimer’s disease, will provide a foundation for developing novel therapeutic approaches to treat or prevent Alzheimer’s disease.